A Modular Framework for Data-Driven Neurogenetics to Predict Complex and Multidimensional Autistic Phenotypes

Project Summary/Abstract
Autism Spectrum Disorder (ASD) can be viewed through three complementary lenses: neurologically, it is linked
to distributed changes in brain structure, function, and connectivity; biologically, it is associated with genome-wide
mutations across multiple pathways; and clinically, it manifests as a diverse spectrum of behavioral and cogni-
tive impairments. Despite this richness, treatment options for ASD are based on coarse diagnostics and target
a few speciﬁc symptoms, such as social awareness, irritability, and depression. As a result, they have varied,
and often limited, efﬁcacy across patients. Taken together, next-generation therapeutics for ASD will crucially
depend on our ability to bridge its neurological, biological, and clinical viewpoints for personalized intervention.
Imaging-genetics is an emerging ﬁeld that attempts to link neuroimaging features with genetic variants. How-
ever, most methods focus on a restricted set of biomarkers, and they do not account for clinical phenotype, both
of which provide an incomplete picture of the impacted processes. Our long-term goal is to develop a modu-
lar platform that fuses multimodal neuroimaging and multi-omics data to unravel the complex etiology of ASD.
The overall objective of this proposal is to develop and validate interpretable deep learning models to combine
genome-wide variants with whole-brain structural and functional MRI data. Our innovative strategy is to use
biologically-informed neural network architectures to project each of the modalities to a shared latent space that
is simultaneously predictive of patient-level clinical phenotype. This unique formulation can easily accommodate
missing data modalities, thus maximally utilizing all of the available information. We will devise, implement, vali-
date, and disseminate our model via four speciﬁc aims. In Aim 1 we will develop a graph neural network, whose
connections mimic a well-known gene ontology. Hierarchical pooling operations will capture the information ﬂow
through the network, while an attention layer will learn the discriminative biological pathways associated with the
phenotype. In Aim 2 we will develop and integrate a Bayesian feature selection procedure to identify ROI-based
neuroimaging biomarkers and a matrix autoencoder to extract discriminative functional subnetworks from brain
connectivity data. In Aim 3 we will use the fused imaging and genetic architectures to uncover the neural and
biological bases underlying the observed clinical heterogeneity of ASD. Finally, in Aim 4 we will package and dis-
seminate our model as a user-friendly tool for the broader research community. We anticipate the proposed work
will have a transformative impact on ASD research by allowing us to develop reﬁned diagnostic instruments
and on the ﬁeld of imaging-genetics by providing a new approach for multimodal biomarker discovery.

Public health relevance
Project Narrative Autism Spectrum Disorder (ASD) is characterized by neurological changes in brain structure and function, genetic variation across multiple biological pathways, and a diverse array of behavioral and cognitive impairments. This proposal will develop novel computational algorithms that fuse multimodal neuroimaging and genetics data to bridge these three viewpoints of ASD. Our algorithms will be used to explore key questions related to the clinical heterogeneity of ASD and will be released as an open-source tool for the broader research community.